Transcriptional Regulation of Alcohol Sensitivity and Tolerance

––– PROJECT SUMMARY –––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––
Resistance to the initial negative, intoxicating effects of alcohol, is a risk factor in the development of alcohol
use disorder. Another hallmark and driver of AUD is tolerance, which develops after repeat exposures. Such
repeat alcohol exposures also lead to expression changes in numerous genes, yet many transcriptional
mechanisms that enact these changes and mediate tolerance and its close relative, dependence, remain to be
elucidated. Transcriptional mechanisms encoding stable changes in gene expression include the modification
of chromatin. One of the lesser studied chromatin-modifying mechanisms is histone methylation, especially
histone demethylating enzymes (HDMs). The goal of this application is to understand the neural, molecular,
and genetic mechanisms of Kdm3 HDM-mediated regulation of initial sensitivity and of acquired tolerance to
alcohol. This is based on our published findings that Drosophila knock out of Kdm3 causes increased initial
sensitivity, and reduced tolerance to repeat ethanol exposure. First, we will determine the neurons and
conserved neurotransmitter systems that require Kdm3 for normal alcohol responses. Second, we will
determine Kdm3-dependent changes in open chromatin induced by alcohol exposure. This will include an
analysis of transcription factors that have binding sites overrepresented in regions of ethanol-induced changes
in chromatin accessibility. Third, we will investigate putative Kdm3-target genes by asking which of them
mediate Kdm3’s effects on alcohol-induced behavior. The premise for each of our aims is supported by
extensive published and preliminary data. Together, the proposed experiments will illuminate mechanisms of
Kdm3-mediated chromatin modifications and gene regulation that mediate alcohol sensitivity and tolerance.
The proposed experiments are highly responsive to the NIAAA Notice of Special Interest NOT-AA-21-029
“Genetics of Alcohol Sensitivity and Tolerance” and will provide an “enhanced understanding of genetic,
genomic, and epigenetic factors contributing to biological processes for individual variation in sensitivity and
the development of tolerance” (NOT-AA-21-029).

Public health relevance
––– PROJECT NARRATIVE ––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––– Alcohol abuse disorders are a chronic human condition where initial consumption leads to long lasting behavioral changes, including tolerance to repeat exposure. The results of the proposed studies will provide valuable mechanistic insight into the initial levels of response to alcohol and into the development of tolerance. This will highlight novel targets for therapeutic intervention with alcohol addiction, which are largely lacking.